Evaluating the Role of Telemedicine in Improving Rural Emergency Department Sepsis Care

Project Summary/Abstract
Sepsis is a life-threatening condition that has doubled in incidence over the past decade, and now constitutes
17% of all in-hospital deaths in the US at an annual cost of $24 billion. Early, aggressive emergency care
saves lives, yet many rural hospitals have low adherence to evidence-based sepsis care guidelines.
Consequently rural sepsis patients have a 38% higher mortality rate. Rural emergency department (ED)-based
telemedicine has been proposed to standardize care and support local clinicians in rural hospitals, but its
effectiveness has never been rigorously tested. With 19% of the US population living in rural areas and an
estimated 5,000 preventable rural sepsis deaths annually in the US, there is a critical need to test strategies to
improve dissemination and implementation of evidence-based sepsis guidelines in rural centers. The goal of
this Career Development Award is to prepare the applicant for a career as a clinical investigator and health
services researcher focusing on comparative effectiveness research of rural acute care interventions. This goal
will be accomplished within the infrastructure of the Rural Telehealth Research Center through (a) specific
graduate coursework, (b) a Mentorship Advisory Committee, (c) carefully selected conferences and
workshops, and (d) a mentored research study. The specific aims of the proposed study are (1) to measure the
association between ED-based telemedicine use, guideline adherence, and clinical outcomes, (2) to measure
the effect of a telemedicine relationship on guideline adherence among patients who have telemedicine
available but not used, and (3) to describe how and why telemedicine use affects clinical care, decision-
making, and dissemination of best practices, using qualitative methods. The proposed mentored research
project will accomplish these aims through an observational cohort study of patients with severe sepsis or
septic shock treated in critical access hospitals in a large Midwestern telemedicine network over a 4-year
period. Our central hypothesis is that telemedicine will improve clinical outcomes through improved adherence
with international sepsis guidelines by changing (1) patient-level recommendations, (2) provider-level behavior,
and (3) hospital-level practices. At the end of this Career Development Award, the candidate will be well-
prepared to become an independent scientist with expertise in rural acute sepsis care, with specific strength in
comparative effectiveness research methods and qualitative methods. Our study findings will serve as the
basis for future studies to understand the role of dissemination strategies (including telemedicine) on
implementing best practices in rural health care settings, which will form the foundation of the candidate's first
R01 submission.

Public health relevance
Project Narrative: Severe sepsis is a leading cause of death in the US, and increased mortality in rural hospitals leads to nearly 5,000 preventable rural sepsis deaths in the US each year. Using comparative effectiveness techniques in a cohort mixed methods study of patients in a large Midwestern rural telemedicine network, this study tests the hypothesis that telemedicine improves quality of care, health, and survival for sepsis patients presenting to rural critical access hospitals. The findings from this study will help prepare the applicant for a career as an independent rural acute care investigator, and they will serve as preliminary data for the applicant's subsequent proposal that will form the basis of his first R01 submission.